Regulation of Basal Endocannabinoid Tone in the Hippocampus

DESCRIPTION (provided by applicant): Endocannabinoids, abundant endogenous lipid molecules, have various neurological functions such as cognitive alteration and neuroprotection. The production of endocannabinoids occurs rapidly in neurons upon a rise in Ca2+ or an activation of G proteins. Once released into extracellular space, endocannabinoids bind to presynaptic cannabinoid receptors and suppress synaptic transmission. Due to rapid production and uptake of endocannabinoids, their action is temporally limited. In addition to this phasic action of endocannabinoid, neurons tonically release endocannabinoid. However, regulatory mechanisms for endocannabinoid tone are largely unknown. Since tonic endocannabinoid level has been implicated in lasting state of neural activity such as anxiety and neurodegeneration, it is possible that the endocannabinoid tone may be regulated by chronic alterations of neuronal activity. The proposed studies aim to track down the cellular and molecular targets of the activity-dependent modification of tonic endocannabinoid signaling. This project will further determine functional significance of endocannabinoid tone in synaptic homeostasis and neurodegenerative disease, both of which involve chronic shift in neuronal activity. Persistent inactivity may induce both synaptic homeostasis and a change in basal endocannabinoid level, but the relationship between the two is poorly understood and therefore is proposed to be investigated here. If endocannabinoid tone is reduced, e.g., by chronic inactivity, the outcome may not be always advantageous, given the various beneficial functions of endocannabinoids. For example, detrimental effects of endocannabinoid deficiency could be accentuated when neuroprotection mediated by endocannabinoids is on high demand. I propose to test for roles of diminished endocannabinoid tone when neuronal activity is reduced in Alzheimer's disease models. The outcome of these studies will provide new perspectives on the regulation of endocannabinoid tone and its roles in physiological and pathological settings.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project aims to study a novel form of endocannabinoid signaling that occurs constitutively in the nervous system. The regulation of basal endocannabinoid tone, which is expected to be uncovered by this study, may be critical for maintenance of neural functions and relevant to a new therapeutic pathway for neurodegenerative diseases. PROJECT NARRATIVE This project aims to study a novel form of endocannabinoid signaling that occurs constitutively in the nervous system. The regulation of basal endocannabinoid tone, which is expected to be uncovered by this study, may be critical for maintenance of neural functions and relevant to a new therapeutic pathway for neurodegenerative diseases. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Endocannabinoids (eCBs), abundant endogenous lipid molecules, have various neurological functions such as cognitive alteration, mood control, neuroprotection, appetite enhancement and pain modulation5. The production of eCBs is stimulated by neuronal activity, specifically by a rise in Ca2+ or an activation of G proteins linked to metabotropic glutamate receptors, muscarinic acetylcholine receptors or dopamine receptors3,80. Once they are released into extracellular space, eCBs bind to presynaptic cannabinoid receptor type 1 (CB1R) and suppress synaptic transmission in a retrograde manner3,130,51,80. The action of eCB is in general temporally limited within minutes because of cellular uptake and enzymatic degradation56. Although the action of eCBs is initiated in an on-demand "phasic" fashion, triggered by neural activity and terminated by uptake and hydrolysis, neurons do tonically release eCB. Biochemical studies show that many brain areas maintain tonic levels of eCBs150,36,46,138. Electrophysiological data indicate that the tonically released eCBs persistently suppress neurotransmission117,99. However, the mechanisms that regulate the tonic release of eCBs are largely unknown. According to behavioral and biochemical studies, tonic eCB levels can be altered by anxiety and neurodegeneration107,76,45,92. It is noteworthy that these forms of modulation are not phasic over the course of minutes, but rather represent chronic shifts in the state of activity. This observation led me to hypothesize that the tonic level of eCBs is regulated by a chronic, long-lasting alteration of neuronal activity. Given the importance of the eCB-mediated retrograde signaling in specific control of network functions, it is possible that the tonically released eCBs also play crucial roles in activity coordination but their significance has not been demonstrated. I have recently found that tonic activation of CB1Rs in hippocampal slice cultures is decreased by chronic blockade of neuronal firing, strongly supporting the hypothesis above. This project will further determine the functional significance of the eCB tone in synaptic homeostasis and neurodegenerative disease, both of which involve chronic shifts in neuronal activity. To test my major hypothesis and further elucidate the functional significance of eCB tone, I propose the following goals. Specific Aim 1 is to test the hypothesis that chronic deprivation of neuronal activity reduces tonic levels of eCB by facilitating eCB degradation. I have recently uncovered a basic mechanism that regulates tonic level of eCBs. My preliminary data show that a blockade of neuronal firing for 3 - 5 days in organotypic slice cultures of hippocampus facilitates the inactivation of tonically released eCB. Neurons produce two major eCB molecules, anandamide35 and 2- arachidonoyl glycerol (2-AG)109,153. My data suggest that 2-AG signaling is unaffected by the activity deprivation, implying an inactivity-induced change in anandamide metabolism. New experiments are proposed to track down the cellular and molecular target of the activity-dependent modification of tonic eCB signaling. Specific Aim 2 is to test the hypothesis that eCB tone has functional significance in network homeostasis during pathological inactivity. In spite of the existence of eCB tone150,36,46,138,117,99, its functional significance still remains elusive. Chronic tetrodotoxin (TTX) used in Aim1 is a straightforward simulation of inactivity, but (patho)physiological relevance of such a complete blockade of firing needs to be tested. In Aim2, I will first ask if the inactivity-dependent modulation of eCB tone is a generally relevant phenomenon in neurodegenerative models where neuronal activity is chronically impaired. Then, I will determine whether the reduced eCB tone contributes to the homeostatic maintenance of network function. During chronic blockade of neural activity, the nervous system maintains excitability within the normal range via homeostatic scaling of synaptic strenghths164,163,29,18,137, but the role of eCB in synaptic homeostasis in poorly understood. My goal is to learn how the decreased eCB tone that results from chronic inactivity contributes to homeostatic plasticity. Specific Aim 3 is to test the hypothesis that inactivity-induced reduction of basal eCB has neurotoxic effects in Alzheimer's disease models. The studies in Aim 2 focus on beneficial roles of basal eCB in homeostatic adjustment of network function. However, a reduced eCB tone may not be always advantageous, given the various beneficial functions of eCBs. A detrimental effect of eCB deficiency could be accentuated when the demand for eCBs is elevated, e.g., in pathological conditions when eCBs would normally provide neuroprotection. I propose to test for the role of diminished eCB tone when neuronal activity is reduced in Alzheimer's disease (AD) models. Because eCBs have neuroprotective roles in AD, I will look for the link between diminished eCB tone and neurotoxicity in the disease model. The outcome of these studies will provide new perspectives on the regulation of eCB tone and its roles in physiological and pathological settings.